Ambient Particle Radioactivity and Lung Cancer Survival

ABSTRACT
Lung cancer persists as a prevalent and deadly disease in the U.S., accounting for 1 in 5 cancer deaths in
2023, with a low survival rate following diagnosis. Ambient particulate matter (PM) is an environmental cause
of lung cancer, with limited data suggesting its association with increased risk and poor survival outcomes.
Particle radioactivity (PR), a radiometric characteristic of ambient PM, is caused by naturally occurring or
anthropogenic radionuclides. Radon decay products can attach to PM2.5 (ambient fine particulate matter
less than 2.5 µm in aerodynamic diameter), which, when inhaled, can be deposited into the lungs and
potentially contribute to cancer development. Lung cancer, particularly non-small cell lung cancer
(NSCLC), is often driven by somatic mutations, which can lead to abnormal cell growth, division, and tumor
formation. Oncogenes (such as EGFR and KRAS) and tumor suppressor genes (such as TP53) are frequently
involved in somatic mutations, driving the development and progression of NSCLC. While some studies have
investigated the effect of ambient PM exposure on lung cancer survival after diagnosis, the impact of
environmental exposure to PM2.5 radioactivity and gene-radioactivity (GXR) interactions on lung cancer
survival remains unexplored. To address these gaps, this R21 exploratory application will examine the
associations between ambient PR exposure and lung cancer survival, utilizing the data from the Boston
Lung Cancer Survival (BLCS) cohort, covering from period 2001 through 2018, with over 100,000 person-
months of follow-up. In Aim 1, we will assess the effects of pre- and post-diagnosis exposures to PR on the
overall survival (OS) and progression free survival (PFS) among the BLCS patients, adjusting for
covariates and indoor radon and ambient PM2.5. In addition, by accounting for interactions with key
covariates, we aim to identify subgroups with poor survival outcomes. In Aim 2, we will investigate the
impact of germline and somatic GXPR interactions on lung cancer survival. This R21 represents a novel and
innovative application of established methodologies for assessing radioactive PM exposure and survival
analysis to explore a new scientific area, with the potential for significant translational impact in reducing lung
cancer mortality.

Public health relevance
Project Narrative The integration of environmental particle radioactivity (PR) exposure data and genomic data in a clinical cancer cohort presents a unique opportunity to identify the main effects of PR- associated poor survival outcomes, while also clarifying genetic variation in such relationships. Because exposures to PR are ubiquitous, our findings may have broad implications for environmental, public health, and medical management policies aimed at improving health outcomes for cancer survivors.